Systems analysis of mitochondrial genome maintenance in physiological context

Project Summary (No Change from Parent Award)
Mitochondrial DNA (mtDNA) encodes RNAs and proteins critical for cell function. However, the
pathways that regulate mtDNA synthesis and segregation in animal cells are not well
understood. The goals of this work are to identify the protein components of mitochondrial DNA
nucleoid complexes, to investigate how mitochondrial replication and dynamics are coordinated
to homeostatically maintain mtDNA nucleoid segregation and abundance, and to probe the
mechanisms underlying selection against mutant mtDNAs in somatic cells. These experiments
will provide fundamental insights into the maintenance of the essential mitochondrial
chromosome in animal cells and how maintenance processes are regulated, potentially leading
to the discovery and characterization of novel pathways that regulate the inheritance of mtDNA
disease alleles. We will employ cutting-edge microscopy of living cells and whole animals,
proteomics, and single cell transcriptional analyses to interrogate the molecular functions of
candidate proteins implicated in the maintenance of mtDNA integrity. These experiments will
reconcile inconsistencies in the mitochondrial biology literature, provide fundamental insight
into the mechanisms of mtDNA copy number control, and identify novel pathways that regulate
the tissue-specific manifestations of mitochondrial dysfunction.

Public health relevance
Project Narrative (No Change from Parent Award) Mitochondria are endosymbiotic organelles that have their own genome and perform many essential functions in eukaryotic cells, including ATP synthesis via oxidative phosphorylation. Mitochondrial DNA (mtDNA) mutations cause heritable respiratory chain deficiency and contribute to a wide spectrum of diseases in humans, including metabolic disease, neurodegeneration, and cancer. The proposed research will define how mtDNA synthesis is regulated at the chromosome, organelle and cellular levels in physiologically relevant cellular and invertebrate models, and how disruption of these processes impinges on mtDNA integrity, cellular homeostasis, and ultimately human health. This work is relevant to the part of the NIH's mission that fosters fundamental basic cell biology discoveries that will directly lead to the identification of new therapeutic targets and therapies for the treatment of a wide array of human diseases.